Core A - Administration

PROEJCT SUMMARY: CORE A
The Administrative Core will provide centralized grant administration, data processing and administrative support
for the projects. This Core will also serve to amalgamate and unify the investigators, their experimental findings
and their ideas, and to track and evaluate research progress and provide organization and leadership directed
toward maintaining a highly integrated program. These efforts will occur by 1) providing administrative services
to the investigators that include management of project supplies, filing, development of memos, meeting minutes
and communications covering all operations, including publications; 2) organizing monthly meetings of program
project personnel, quarterly meetings of the Program Steering Committee, annual review meetings that include
both the Internal and External Advisory Board members; 3) maintaining integration activities that include data
sharing, rapid publication efforts, and identifying and instituting other novel activities critical to maintaining and
strengthening program integration; and 4) providing overall fiscal review, accounting, and real time budgets
analyses that include reports, verbal communications, reviews and forward-looking projections on expenditures.

Public health relevance
PROJECT NARRATIVE: CORE A The Administrative Core is essential to facilitate efficient and effective functioning of all components of this Program Project. Together, the several program components linked through the Administrative Core serve as an engine for discovery in the three separate but integrated cancer cachexia signaling pathways and for translating these basic discoveries into novel therapies for the treatment of this debilitating condition.